Gestational Diabetes Mellitus, Perinatal Depression, and Offspring Neurodevelopmental Phenotype

PROJECT SUMMARY
This K99 application aims to determine pathways by which gestational diabetes mellitus (GDM) and prenatal
depression affect postpartum maternal mental health, neonatal brain function, and toddler brain-behavioral
development. There is a bidirectional association between GDM and depression which affect approximately
10% and 13% of women in the United States respectively and disproportionately affect women from ethnic and
racial minority groups. Both conditions are independently associated with adverse neurodevelopmental
outcomes in offspring including increased risk for social-emotional and attentional deficits. Despite the

Public health relevance
PROJECT NARRATIVE This K99 Career Development Award seeks to provide the applicant training in perinatal women's mental health with a dyadic focus, perinatal maternal immune function, pregnancy morbidity and health disparities, and biostatistics under a Developmental Origins of Health and Disease (DOHaD) framework to support the applicant's transition to research independence. Through the training embedded in this award, the applicant will develop the skills and expertise necessary to build a translational research program that will examine pathways by which perinatal maternal health factors affect offspring brain and behavioral development and risk for neurodevelopmental disorders. This approach will ultimately identify mechanisms, markers, and modifiable risk factors relevant to both maternal mental health and child neurodevelopmental outcomes.